Preventing Therapeutic Resistance in RAS-mutated Pediatric Cancers

Project Summary/Abstract
For pediatric patients with RAS-mutated tumors, clinical trials testing targeted therapies are limited due to the
paucity of preclinical data. This is unfortunate, as targeted therapies have the potential to make a significant
impact on morbidity for pediatric patients. Cytotoxic agents significantly delay normal childhood development
leading to lifelong sequalae. In contrast, targeted therapies that preferentially attack RAS-mutated tumor cells
while sparing normal developing tissue can limit unwanted sequalae and enhance overall outcomes for pediatric
cancer patients. Unfortunately, single-agent targeting of RAS-mutated cancer cells using either MEK inhibitors
or mutant RAS inhibitors is largely ineffective; resistance rapidly develops due to upregulation of multiple RTKs
and subsequent hyperactivation of WT RAS signaling. Thus, alternative therapeutic approaches are needed to
treat RAS-mutated pediatric cancers. Toward this end, we take two complementary approaches at inhibiting WT
RAS signaling designed to enhance the effectiveness of targeted therapies in RAS-mutated pediatric cancers.
While each approach seems obvious in hindsight, neither has been tested in pre-clinical models of RAS-mutated
pediatric cancers.
We first examine the extent to which broad inhibition of proximal RTK signaling using inhibitors to the common
proximal RTK signaling intermediates SHP2 or SOS1 enhances the efficacy of and delays therapeutic resistance
to MEK or mutant RAS inhibitors in RAS-mutated non-CNS pediatric cancer cells. Since MEK inhibition induces
compensatory RTK-dependent signaling cascades, co-targeting RTK signaling with MEK is an attractive
approach to treat RAS-mutated pediatric cancers. However, studies in multiple RAS-mutated cancers revealed
that the specific RTK that is reactivated can vary between cell lines or studies, even within the same cancer type.
Thus, rather than using specific RTK inhibitors that may differ for each patient, we inhibit the common proximal
RTK signaling intermediates SHP2 or SOS1, and use both pharmacologic and drug resistance assays to
determine which drug-drug combinations are the most potent at enhancing drug killing and inhibiting therapeutic
resistance. We then test the most promising therapeutic combinations in patient-derived xenograft models.
As a second approach, we determine the extent to which combined inhibition of mutant RAS and WT RAS
effector signaling enhances the efficacy of and delays therapeutic resistance to mutant RAS inhibitors in RAS-
mutated non-CNS pediatric cancer cells. RAS proteins show differential activation of RAF and PI3K pathways:
HRAS potently activates PI3K but poorly activates RAF, whereas KRAS potently activates RAF but poorly
activates PI3K. Since both MEK and PI3K pathways must be inhibited for effective killing of RAS-mutated
pediatric cancers, we use this fundamental understanding of signaling differences between mutant RAS family
members to examine rational therapeutic approaches in RAS-mutated non-CNS pediatric cancer cells. We then
test the most promising therapeutic combinations in patient-derived xenograft models.

Public health relevance
PROJECT NARRATIVE In RAS-mutated pediatric non-CNS solid tumors, WT RAS signaling underlies therapeutic resistance to therapies targeting either MEK or mutated RAS. This proposal takes a rational approach to assessing combination therapies to designed to treat RAS-mutated pediatric solid tumors that is based on first-principles of inhibiting both mutated RAS and WT RAS signaling to downstream effectors. Hence, this research will inform novel therapeutic approaches designed to prolong the therapeutic window for current targeted therapies and potentially enhance patient survival.